Mapping the gene regulatory architecture of pancreatic islet-specific cell types to diabetes

PROJECT SUMMARY/ABSTRACT
Pancreatic islets are comprised of a plurality of diverse hormone-secreting cell populations that collectively
contribute to the maintenance of glucose levels throughout the body over time. Dysfunction in the insulin
secreting cells of pancreatic islets – beta cells – are a key determinant underlying liability to multiple forms of
diabetes as well as disease complications that arise from glucose dysregulation over a patient's lifetime. The
mechanistic programs that operate to coordinate gene regulation in islet cells which ultimately contribute to
disease is not fully understood, limiting progress to understanding disease and its progression. Ongoing work by
our team members, the Human Pancreas Analysis Program (HPAP), and other investigators are generating a
wealth of single-cell data in the pancreas that provide the exquisite opportunity to address this gap in knowledge
and improve care of patients with diabetes. To address this gap, we have assembled a multidisciplinary team
with over 15 years of collaborative work dissecting the architecture of diabetes, who have also pioneered the
creation of portals to aggregate and disseminate knowledge. In Aim 1, we will create the largest map of islet cell
types by integrating single cell gene expression and accessible chromatin from publicly available and newly
generated data. We will use these resources to map genetic determinants of these molecular phenotypes across
islet cell types and identify causal variants, linking them to diabetes and glycemic traits. In Aim 2, we will use
these aggregated data to generate regulatory circuitry in each cell type by linking cis-regulatory elements (cREs),
transcription factors predicted to regulate them, and the target genes for cRE activity. We will use these circuits
to predict pre-diabetes and type 2 diabetes, as well as to explain heritability in genetically determined diabetes
subtypes. To prepare for increasing data generation, in Aim 3, we will implement pipelines used for our activities
for robust integration with the Cardiometabolic disease Knowledge Portal (CMDKP) and will house summary
data generated by the project in this resource, which will allow maximum benefit and use for exhaustive linkage
of discoveries to diabetes and related traits. We will then apply our single-cell resources to expand into existing
collection of bulk tissues, to improve power for discovery and characterization of the regulatory architecture of
pancreatic islet specific cell types. The project will result in novel, large scale resources immediately applicable
to understand the mechanisms underlying diabetes and disease progression.

Public health relevance
PROJECT NARRATIVE A wealth of newly generated data collected in the cell types of pancreatic islets at the resolution of single cells offer an incredible opportunity to better define the genes and mechanisms underlying susceptibility to diabetes and disease progression. The proposed project aims to integrate these data to create the largest molecular profiles of all cell types in islets to date, identify genetic factors that influence gene regulation and link to disease, and define maps of regulatory circuits that coordinate gene expression and predict disease. Our resulting maps will then be disseminated within Knowledge Portals to facilitate community used and accelerate discovery.